Alcohol and calorie-dense diet-mediated hepatic mitochondrial dysregulation

1 Abstract
2 The goal of this Ruth L. Kirschstein
3 career. The applicant’s career development will come in large part from work in hepatic models of alcohol, high
4 fat, and high sucrose exposure. The applicant will have the invaluable opportunity to conduct high quality
5 research using a well-established preclinical macaque model of chronic binge alcohol (CBA) administration and
6 an in vitro HepaRG spheroid cell culture model of hepatocytes. Alcohol-related liver injury is a leading cause of
7 end-organ disease, and the combined impact of alcohol and a calorie-dense diet on liver pathophysiology has
8 yet to be well characterized. Several studies of either alcohol- or high fat diet-related liver injuries demonstrate
9 that mitochondrial oxidative phosphorylation (OXPHOS) and remodeling (biogenesis and dynamics) are
10 decreased or disrupted in response to alcohol or high fat. Data from the laboratory showed CBA-mediated
11 decreased hepatic expression of genes involved in mitochondrial biogenesis, OXPHOS, and fusion such as
12 peroxisome proliferator-activated receptor-g coactivator-1b (PGC-1b) and mitofusin-2 (MFN2) in control diet-fed
13 macaques. Additionally, preliminary data generated for this proposal from liver biopsies of short-term high fat,
14 high sucrose (HFS) diet (HFSD) fed macaques showed increased expression of genes involved in lipid
15 accumulation. Previous work from the laboratory demonstrated that alcohol dysregulates mitochondrial
16 remodeling and bioenergetics in skeletal muscle and immune cells. Taken together, preliminary data and
17 published literature provide evidence of alcohol-mediated mitochondrial adaptations leading to end-organ injury.
18 Thus, the hypothesis of the proposed project is that alcohol and HFSD together disrupt mitochondrial remodeling,
19 decrease OXPHOS, and increase lipid accumulation in the liver, and that promoting PGC-1b expression
20 ameliorates these changes in hepatocytes. Using livers from CBA or vehicle administered HFSD-fed macaques
21 at multiple timepoints and an in vitro model of alcohol and HFS-treated hepatocytes, the applicant aims to test
22 that alcohol and HFS disrupt hepatic mitochondrial remodeling, decrease hepatic OXPHOS, and increase
23 hepatic lipid accumulation. Further, whether or not promoting hepatocyte PGC-1b expression will ameliorate
24 these alcohol and HFS-mediated alterations will be determined. Findings from the proposed studies will provide
25 insight into metabolic dysregulation caused by alcohol in the context of HFSD. Additionally, the project aims to
26 show that PGC-1b overexpression increases mitochondrial biogenesis, fusion, and OXPHOS and has the
27 potential to improve liver health in alcohol- and HFSD-induced liver injury. With a strong mentoring team
28 dedicated to developing a well-rounded physician scientist, completion of the proposed training plan in alcohol
29 abuse-related research will ensure that the applicant is equipped for a successful career in academic medicine.
NRSA F30 application is to prepare the applicant for an academic medical

Public health relevance
Project Narrative This NRSA F30 fellowship will provide an invaluable training opportunity for a future physician scientist as she develops into an emerging leader in the field of alcohol-related liver injury. The proposed studies will investigate alcohol and calorie-dense diet-mediated disruption of hepatic mitochondrial processes and lipid handling. The findings from these studies will provide correlative and mechanistic insight for future translational studies and therapeutic applications aiming to alleviate the combination of alcohol and metabolic-induced liver injury.